Leukocyte-endothelial cell interaction in aging

DESCRIPTION (provided by applicant): It has become increasingly apparent that epigenetics, where the genome interacts with the environment, is central to our understanding of the relationship between aging and disease. DNA methylation is a key epigenetic mechanism controlling gene expression. Recent data suggest that there is a considerable epigenetic drift in aging, resulting in relative DNA hypomethylation in many tissues including T cells. The original RO1 was funded to examine the effect of aging on the epigenetic control of leukocyte chemokine system. We showed that aging is associated with increased T cell pro-inflammatory chemokine function that is at least in part controlled by DNA methylation. In this competing renewal, we will determine if the aging changes can be ameliorated by altering the T cell epigenome during the critical stages of immune system development. We hypothesize that the prenatal 'epigenetic environment' can modify T cell chemokine receptor response that will in turn determine the late-life susceptibility to chronic inflammatory diseases. Specific Aim 1 will determine the effect of a pre-natal methyl-donor supplementation diet on murine T cell chemokine function throughout the life span. Specific Aim 2 will assess the consequence of diet-induced epigenetic changes on the onset and progression of coronary artery disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: The mechanistic link between aging and chronic diseases in the elderly is poorly understood. Using mouse models, the proposal will examine the effect of a pre-natal methyl-donor supplementation diet on the onset and progression of coronary artery disease in late life. The mechanistic link between aging and chronic diseases in the elderly is poorly understood. Using mouse models, the proposal will examine the effect of a pre-natal methyl-donor supplementation diet on the onset and progression of coronary artery disease in late life. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS T cells chemokine response is a critical early event in the pathogenesis of many common inflammatory diseases in the elderly. However, despite the importance of the chemokine network in health and diseases, very little was known about the effect of aging on the T cell chemokine system when the RO1 was originally funded. Works done by the PI's group over the past several years in murine systems and in humans have demonstrated that aging is associated with increased pro-inflammatory chemokine response that is at least in part due to age-related T cell DNA hypomethylation. The prenatal methyl environment has recently been found to be an important determinant of immune function in the offspring. We propose in this renewal application to determine if a prenatal maternal methyl-donor supplementation diet can "restore" leukocyte chemokine receptor (CCR2 and 5) function to that seen in the younger age group, and to examine the transgenerational effect of the diet on the development of cardiovascular disease in aging. Hypothesis: Epigenetic modification through dietary methyl-donor supplementation during the critical stages of immune development will ameliorate aging-associated T cell DNA hypomethylation. This in turn will lessen pro-inflammatory CC chemokine receptor (CCR2 and CCR5) response, and reduce the burden of coronary artery disease during aging. Specific Aim 1. To define the transgenerational effect of a prenatal epigenetic diet on T cell chemokine receptor expression and function. These studies are designed to test the first part of the stated hypothesis that environmental exposure altering the epigenome during the critical period of leukocyte development has important long term immune consequences. Specific Aim 1 will determine the effect of a prenatal methyl-donor supplementation diet on chemokine receptor function on T cell subsets (CD4, CD8, naïve/memory, Th1/2, Treg, CD28 negative) and monocytes of F1 generation animals throughout the life span. In addition, chemokine receptor expression following cytokine (IL-2, 4, 7, 15, GM-CSF) stimulation will be determined (the abbreviations used in the proposal is attached at the end of the proposal). This will be done during the first 3 yrs of the proposal. 1. Life span and mortality studies will be performed to assess the overall effect of the prenatal diet on the longevity and immune function of the F1 mice. 2. Chemokine receptor gene expression and promoter methylation status will be assessed by microarray, real time PCR, and bisulfite pyrosequencing. 3. Protein expression will be measured by flow cytometry and Western immunoblotting. 4. Functional effect will be tested by in vitro and in vivo chemotactic assays. Specific Aim 2. To assess the effect of the methyl-donor supplementation diet on the progression of atherosclerosis. These experiments are designed to test the second part of the stated hypothesis that prenatal maternal methyl-donor dietary supplementation has long term health consequence and can reduce the onset and progression of atherosclerosis. ApoE-/- mice will initially be crossed with CCR2, CCR5, or DNA methyltransferase 1 (+/-) knockout mice, then subject to the prenatal diet manipulations. The offspring will then be allowed to age. This will be done during year 3-5 of the proposal. 1. T cell and monocyte chemokine receptor expression and function will be determined as in Aim 1. 2. Morphological analysis of atherosclerotic lesions will be done to quantify the effect of the prenatal diet on atherosclerosis in aging.